Integrated Current Population Survey Data for Population Dynamics and Health Research

Project Summary/Abstract
The parent grant for this administrative supplement request aims to expand and improve IPUMS CPS, an
essential data resource for research on population health and child well-being in the United States. IPUMS CPS
streamlines access and reduces technical barriers to analyzing data from the Current Population Survey (CPS),
the nation's most comprehensive source of data on the economic and social well-being of US individuals and
families, including women of reproductive age and children. IPUMS CPS enables rigorous and reproducible
research on population dynamics and the social and economic contexts in which health inequities are created
and reinforced, enabling public policy based on sound scientific evidence.
The parent project’s goal is to ensure broad access, timely delivery, and innovative use of CPS data for
population dynamics and population health research. This administrative supplement request represents a third
set of improvements related to decreasing data processing times to reduce the time to deliver new data to the
research community and reduce the costs of maintaining the infrastructure over the long run. The supplement
request has three specific aims: (1) Automate the testing process in response to code changes; (2) Shift
integration testing earlier in the workflow; (3) Enhance difference reporting. These enhancements will be a
massive time saver for IPUMS data production, but the research community is the true benefactor in the form of
access to higher quality data more quickly.
Sophisticated testing requires close collaboration between data content experts and software engineers. The
administrative supplement request proposes a new collaboration between a research programmer analyst and
software engineers to develop a more robust and reliable suite of data production tests and better integration
testing that occurs earlier in the data harmonization process. The tests will improve the data production process,
resulting in more effective testing for quality assurance and more rapid delivery of data, for both IPUMS CPS
and each of the 13 IPUMS data collections built on the shared IPUMS Platform.

Public health relevance
Narrative IPUMS CPS is essential data infrastructure for research on population health and child and family well-being in the United States. IPUMS CPS streamlines access to the Current Population Survey (CPS)—the nation’s primary source of timely data on monthly labor force statistics and the economic and social well-being of its people—by harmonizing, documenting, linking, and freely disseminating CPS data through a powerful data access platform. IPUMS CPS dramatically reduces the cost and increases the rigor and reproducibility of the research on population dynamics and population health with transformative implications for public health.